The role of retrotransposonable elements in neurodevelopment and disease

ABSTRACT
Retrotransposable elements (RTEs) are genomic elements that have the ability to “copy-and-paste” themselves
into new locations within the genome. RTE mobilization can cause mutations and genomic instability. Many
cellular mechanisms exist to repress RTE activity. Interestingly, it has been observed that neural stem and
progenitor cells (NSPCs) show high levels of RTE activity. However, it is currently unknown whether this RTE
activity is essential for normal development of the brain. Further, abnormally high RTE activity has been
associated with a number of neurodevelopmental disorders. Causative roles for RTE expression and mobilization
in neurodevelopmental disorders have not been identified. The long term objectives of this proposal are to
understand whether RTE activation is necessary for normal development and whether RTE inhibition is a viable
treatment for neurodevelopmental disorders. In my first specific aim, I will test the impact RTE expression and
mobilization has on Drosophila brain development and on cerebral organoid development. Drosophila and
cerebral organoids will be treated with Nucleoside Reverse Transcriptase Inhibitors (NRTIs) to prevent RTE
activity. Single-cell RNA sequencing will reveal the cell-type specific differences between control models and
models treated with NRTIs. In my second aim, I will investigate the mechanism by which unrestricted RTE activity
can cause microcephaly. Preliminary data shows increased NSPC death in a Drosophila model of microcephaly.
I will determine whether this is true in multiple other microcephaly models and determine if DNA damage caused
by RTE activation in Drosophila microcephaly models leads to the NSPC death observed. The proposed
research will illuminate the role of RTE activity during neurodevelopment. Importantly, it will also provide crucial
information to inform whether inhibition of RTEs during development is a viable therapeutic for microcephaly and
other neurodevelopmental diseases that are caused by RTEs, thus prompting future pre-clinical studies.

Public health relevance
PROJECT NARRATIVE Retrotransposonable elements (RTEs) which are genomic elements that have the ability to replicate and insert themselves into new genomic locations through RNA intermediates, are largely silenced in most cell types, but are active during neurodevelopment. Overly active RTEs have been correlated with a number of neurodevelopmental disorders, but discrete mechanistic roles remain elusive. This proposal aims to understand whether RTE activity regulates neurodevelopment, the mechanisms by which overactive RTEs can cause diseases, and whether inhibiting RTE activity can prevent neurodevelopmental disorders such as microcephaly.